Fundamentals in Bioinformatics (FunInBio): Expanding Continuing Education Opportunities for Post-Doctoral Scientists

PROJECT ABSTRACT
The Fundamentals in Bioinformatics (FunInBio) program develops, deploys, and evaluates a
continuing education program to address skills gaps in post-doctoral scientists. The FunInBio
curriculum conveys bioinformatics skills while participants contribute to a citizens science research
problem about the environmental component of antibiotic resistance. Participants will gain exposure to
many facets of computational biology, including genome sequencing/analysis, comparative genomics,
and training tailored to their professional needs. FunInBio is directed towards post-doctoral scientists
from universities that employ scientists who would benefit from bioinformatics training. In Aim 1, we will
develop a three-part curriculum covering programming background, an in-person short course on
comparative genomics, and customized online modules tailored to participant needs. In Aim 2, we will
deploy the FunInBio curriculum at regional educational institutions in the life sciences. In Aim 3, we will
assess the effectiveness and outcomes of the FunInBio continuing education program to iteratively
improve our curriculum. Integral to these courses is the program website, developed as a repository for
educational material and a database that aggregates course-generated data. The primary outcome of
FunInBio is the group of early-career scientists trained in bioinformatics skills. In addition, we will
publish our course materials to extend the impact of our curriculum, and we will publish results
quantifying the effectiveness of our approach. FunInBio will bring bioinformatics education to the
growing population of post-doctoral scientists as they address a meaningful research question through
citizen science.

Public health relevance
PROJECT NARRATIVE The Fundamentals in Bioinformatics (FunInBio) program develops and deploys a research-based continuing education course for post-doctoral scientists. FunInBio imparts bioinformatics skills while fulfilling the needs of scientific enterprises undergoing a transition toward increasing large datasets well-suited for computational biology. Course modules are directed at tackling the real-world problem of antibiotic resistance.